Advanced Mass Spectrometry Facility

Historically the facility has supported on the order of 40 PIs each year involved with around 70 annual report level projects with around two-thirds of these projects coming from the NIDDK.

Although useful metrics for some things, the PI-count and project-count are oversimplifications. It is important to note that the amount of support provided to each project varies widely. For instance, support of small molecule chemists at NIDDK and a number of projects involving biopolymer analysis at NIDDK were very involved while most of the support provided to non-NIDDK labs involved one or two low staff time experiments. Support of Kenner Rice (NIDA) is a special case as he only recently moved to NIDA from NIDDK and has had a long-standing working relationship with the facility in all its historical forms.

In addition to working in direct support of PI projects staff and resources are used to update methodology, adopting new and proven approaches of clear importance to the NIDDK PI community and in a limited number of cases developing new approaches when these are of immediate importance to on-going PI projects and otherwise consistent with the facility's technical philosophies.

Continued the long internal project of developing a reliable XL-MS analysis pipeline with a successful solution of the quantitation problem with an original effort of refactoring of software for the inclusion of observations reported by the developers of MaxQuant regarding recognition of DSSO linked peptides' fragmentation suspended because of there being no clear advantage relative to our internal+mascot approach and faiure of the MaxQuant option to allow modification (perhaps this will change in newer versions). Adopted and refined a new method for extracting proteins from gels based on PEPPI (but modified to make it more predictable). Applied this to several projects (for example with Andy Golden and Harris Bernstein).